Investigating Neutrophil Apoptosis as a Therapeutic Target in Alzheimer's Disease

Project I: Summary
Chronic systemic inflammation and immune activation are associated with Alzheimer’s disease (AD)
pathogenesis, and neuroinflammation mediated by astrocytes and microglia is observed in the brain prior to the
onset of cognitive decline. However, there is a need to delineate contributions of other inflammatory cells to AD,
particularly those that can be targeted in the periphery. The overall goals for this study are to 1) determine if
altered neutrophil lifespan exacerbates neuroinflammation and cognitive decline in AD mouse models, and 2)
investigate neutrophil cell death as a potential therapeutic target in AD. There is strong published evidence that
neutrophils are dysregulated in AD and exacerbate disease pathogenesis. In humans and AD mouse models,
neutrophils infiltrate the brain vasculature and parenchyma and neutrophil activation in the periphery
corresponds with disease progression. In addition, several studies have demonstrated that depleting neutrophils
results in cognitive improvement in a familial AD mouse model. While aberrant neutrophil responses damage
tissue and contribute to neurodegeneration, appropriate responses could be helpful in containing inflammatory
stimuli (e.g., infection, amyloid beta, myelin debris) and participate in tissue repair. This balance between
damage and beneficial physiological function is maintained by tightly regulated neutrophil lifespan. Under
homeostatic conditions, neutrophils are short-lived, spending only a few hours in circulation on average. Our
hypothesis is that delayed neutrophil apoptosis in AD contributes to increased neutrophils, neutrophil-mediated
inflammation, and AD pathogenesis. This hypothesis is based on compelling evidence from published work and
our preliminary data. The pathways that regulate neutrophil apoptosis are dysregulated in Alzheimer’s disease
(MAPK and NFkb/TNFa signaling). In addition, delayed neutrophil apoptosis has been shown to result in
increased neutrophil extracellular trap (NET) release, and NET release is a component of AD pathogenesis.
Finally, our preliminary data demonstrate that neutrophil apoptosis is altered in AD mouse models and this
associates with markers of NET release. We will address our hypothesis and achieve our study goals by pursuing
the following two aims: 1) Investigate the hypothesis that altered neutrophil apoptosis is a therapeutic target in
AD using mouse models; and 2) Determine if neutrophil apoptosis and NETosis are altered in persons with AD.
This project is significant and transitionally innovative because neutrophil apoptosis represents a promising
therapeutic target based on the following: 1) apoptosis and clearance of neutrophils are fundamental to the
resolution of inflammation, a known factor in AD pathogenesis; 2) promoting neutrophil apoptosis can dampen
inflammation without severely compromising host defense; and 3) neutrophils can be targeted in the periphery.
The data from these aims will provide the foundation to investigate therapeutics targeting neutrophil apoptosis
in vivo in mouse models and have the capacity for significant translational impact on promising future AD
treatment options.